DIETARY SUPPLEMENT FOR MANAGING NUTRITIONAL DEFICIENCIES IN SICKLE CELL DISEASE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Abstract of project: Experiments are being conducted to develop an appropriate dietary supplement directly addressing malnutrition in sickle cell anemia (SCA) pathology. A supplementation study conducted over 4 months, will test the efficacy of the supplement. Measurements include indirect calorimetry, anthropometry, body composition by Dual X-Ray Absorptiometry (DEXA) and circulating levels of inflammatory proteins by luminex assay in undernourished children (6 [unreadable]12 y) with SCA and healthy controls. Specific aims are: 1. to develop a customized nutritional supplement for SCA children, based on estimated requirements for excessive protein and energy metabolism plus specific amino acid deficiencies and 2. to investigate the efficacy of the supplement in undernourished SCA children by measuring temporal changes in resting energy expenditure;reticulocyte count;weight, height and body composition;circulating amino acids;markers of oxidant damage;Pro- and anti-inflammatory protein.